Perspectives on Participation and on Financial Relations

This is a qualitative study investigating research participants views on financial relationships in research. Up to 40 research participants in NIH intramural studies will be interviewed and asked to comment on several hypothtical scenarios about investigator financial relationships. Questions will focus on what participants would want to know and what might affect their willingness to participate in a particular study. Interviews have been conducted with 33 individuals. Concurrent analysis is underway.